Efficacy of Enhancing Low Vision Mobility thru Visual Training in Virtual World

DESCRIPTION (provided by applicant): NEI's National Plan for Eye and Vision Research has identified Low Vision and Blindness Rehabilitation as one of the most pressing needs and opportunities in vision research. Since most low vision (LV) patients nowadays have useable vision, an important aspect of LV rehabilitation is to maximize the use of the patient's remaining vision. Visual skills are especially important in tasks such as traveling independently through busy streets, in which distant, rapidly changing events have direct impact on the patient's task efficiency and safety. The patient has to learn new information acquisition skills to compensate for their impaired vision. Current LV training for such skills is done on real streets in a one-on-one, trainer/trainee sessions. This way of training, however, usually does not expose clients to all the circumstances that they need to deal with, usually does not provide graded levels of task difficulty and repeatable conditions that facilitate learning, and cannot meet the needs of the majority of LV patients because of the shortage and the high cost of LV trainers and. The advances of virtual reality (VR) technology have made it possible and affordable to build VR systems that can realistically simulate complex and dynamic multi-sensory environments to facilitate LV rehabilitation. However, the most important first step in applying VR technologies to LV rehabilitation is to determine whether the visual experiences of a LV person can be transferred to the real world. Only when a positive transfer of visual skills is confirmed, can subsequent development of comprehensive VR training systems for all aspects of LV rehabilitation become worthwhile. The purpose of the proposed study is to accomplish this first step. A set of visual skills for a most visually challenging task, crossing a signal-controlled street, are selected from standard orientation and mobility curriculum to study virtual experience transfer. Existing technology will be used to build a desktop computer based VR simulator that can generate virtual street intersection scenarios that contain visual and auditory information required for practicing the skills to be studied. Forty-eight LV persons will be recruited from a university LV rehabilitation facility. They will be randomly assigned to practicing the selected visual skills at real, virtual or no street intersections. Their skill levels will be evaluated at real intersections before, immediately after and one month after their scheduled trainings. The primary outcome of interest is the mean change of visual skills between pre- and post-training evaluations in the three groups. Data of visual functions, visual search performance, the sense of presence in VR, subjective rating of task difficulties, and the usefulness and satisfaction of the training sessions will also be collected and analyzed. The long-term goal is to develop interactive VR training systems that have multiple sensory and motor input and output modules and that incorporate the collective experiences of the LV rehabilitation profession. Adding such systems to LV curriculum can greatly improved the affordability, accessibility, efficiency and the scope of LV rehabilitation. PUBLIC HEALTH RELEVANCE: Low vision patients have difficulty acquiring sufficient visual information in a timely manner for the purpose of performing challenging daily tasks, such as traveling independently and safely through busy streets. The advance of virtual reality techniques has provided a potential platform for training low vision patients to use their remaining vision more efficiently, but the key issue is always whether the patient's visual experiences in a virtual world can be transferred to the real world. The proposed study is designed to provide definite answer to this question.

Public health relevance
Project Narrative Low vision patients have difficulty acquiring sufficient visual information in a timely manner for the purpose of performing challenging daily tasks, such as traveling independently and safely through busy streets. The advance of virtual reality techniques has provided a potential platform for training low vision patients to use their remaining vision more efficiently, but the key issue is always whether the patient's visual experiences in a virtual world can be transferred to the real world. The proposed study is designed to provide definite answer to this question.